Advancing mechanistic understanding of membrane ion and lipid transport

SUMMARY
Dynamic trans-bilayer movement of ions and phospholipids across cell membranes is vital for cellular
life and death. In stark contrast to our extensive understanding of membrane ion transport, the mechanisms
and consequences of phospholipid flip-flop remain elusive. The TMEM16 transmembrane protein family,
implicated in various diseases, such as heart attack, stroke, epilepsy, muscular dystrophy, cancer, and
infections like AIDS and COVID-19, comprises both ion channels and lipid scramblases. By closely examining
TMEM16 family members, our previous work has eliminated the conceptual barrier between ion channels and
lipid scramblases, the two major types of passive transporters on cell membranes cooperating distinct
substrates. This conceptual breakthrough has allowed us to determine novel ion and lipid transport principles
at the molecular level and uncover new cellular and physiological functions for TMEM16 ion channels and
lipid scramblases. In this application, we will investigate TMEM16 lipid scramblases to deepen our
understanding of lipid flip-flop and its undiscovered cell signaling roles. We aim to develop innovative methods
for monitoring and controlling lipid flip-flop under physiological conditions and to decipher how calcium and
voltage activate TMEM16 lipid scramblases at molecular and cellular levels. Additionally, we will employ our
novel methods to explore lipid scramblase-mediated cell signaling during cell-cell fusion, an essential yet
poorly understood process for human health. Our proposed studies will offer a comprehensive understanding
of lipid and ion transport in health and disease, paving the way for developing new therapies to prevent and
treat a wide array of diseases, including stroke, heart attack, atherosclerosis, neurological disorders,
infectious diseases, and pregnancy complications.

Public health relevance
Project Narrative: This grant application will investigate the poorly understood membrane lipid flip-flop dynamics at molecular and cellular levels, aiming to elucidate its mechanisms in health and disease, and to facilitate the development of novel therapies for conditions like stroke, heart attack, cancer, pregnancy complications, neurological disorders, and infectious disease including AIDS and CoVID19.